Epigenetic mechanisms of intestinal stem cell fate conversion in response to severe radiation injury

ABSTRACT
Gastrointestinal acute radiation syndrome (GI-ARS) results in high mortality after radiological disasters and
there is no FDA-approved countermeasure to mitigate its effects. The pathophysiology of GI-ARS derives from
severe damage of intestinal crypt epithelial cells, with associated villus shortening, epithelial desquamation,
and loss of barrier function. Sepsis and death can occur if endogenous regeneration of the intestinal epithelial
barrier is not successful. Strategies to augment this post-radiation intestinal regenerative capacity may yield
strategies to mitigate the toxicity of GI-ARS at time points after the first 24 hours post-radiation exposure.
Under normal conditions, multipotent intestinal stem cells marked with the protein Lgr5 (Lgr5+ ISCs) support
the multilineage repopulation of the high-turnover intestinal epithelium from their position at the base of the
small intestinal crypt. These ISCs are ablated after high-dose radiation exposure. However, we and others
have shown that a “revival stem cell” population (revSC), marked by the protein Clusterin (Clu), arises in the
intestinal epithelium after severe radiation injury. However, only a subpopulation of these Clu+ revSCs can
regenerate the radiation-ablated ISC population to support the restoration of the intestinal epithelial layer. Such
stem cell-associated cell state changes typically rely upon rapid epigenetic and transcriptional reprogramming,
but the mechanisms underlying the transition of revSCs to new Lgr5+ ISCs that are required for repopulating
the irradiated small intestines remain poorly understood. This proposal endeavors to comprehensively examine
the epigenetically-regulated and transcriptionally-dependent transitions, and the molecular factors upon which
these transitions occur during these cell state changes. We will utilize well-defined genetically engineered
lineage tracing and reporter mouse models that permit specific isolation of unirradiated Lgr5+ ISCs, radiation-
induced Clu+ rev-SCs, and post-radiation rev-SC-derived Lgr5+ ISCs. Aim 1 proposes to perform an integrated
analysis of RNA-seq and ATACseq data derived from flow-sorted populations of mouse intestinal cells
harvested 3 and 4 days after in vivo abdominal radiation (14 Gy, ~LD50), testing the hypothesis that each cell
state critical to small intestine radiation response exhibits discrete epigenetic regulatory and transcriptional
landscapes. Aim 2 proposes to employ CRISPR screening using a library containing sgRNAs against
epigenetic and transcriptional regulators, with a FACS-based CRISPR screen on irradiated mouse organoids
bearing Clu-CreER; LSL-tdTomato reporter to identify regulators of revSC induction 3 days after irradiation and
a dropout screen to identify those regulators essential for post-revSC repopulation of small intestinal epithelial
cells. The results of this project will identify crucial epigenetic regulators of post-radiation intestinal recovery.
The ultimate objective is to unveil new mitigation strategies for GI-ARS after radiological disasters by
promoting the regeneration of new Lgr5+ ISCs post-irradiation to restore homeostasis of the damaged small
intestines.

Public health relevance
PROJECT NARRATIVE Medical countermeasures do not exist to mitigate high-dose radiation-induced damage to the gastrointestinal tract, so gastrointestinal acute radiation syndrome (GI-ARS) provokes high mortality after radiological accidents. This project proposes a series of experiments to understand the specific cell populations responsible for repopulating the intestine, using a model system mimicking GI-ARS. Successful completion of the proposed aims will provide a foundation for future development of rational strategies to mitigate GI-ARS in the event of radiological accidents/disasters or other settings of abdominal radiation exposure.